Acute Hepatic Porphyrias: Pathogenesis & Treatment

DESCRIPTION (provided by applicant): The overall goal of this NIDDK Mentored Research Scientist Development Award is to provide an integrated research and educational program for the applicant that will lead to an independent academic career in translational research. Robert J. Desnick, PhD, MD, Professor and Chair of Genetics and Genomic Sciences and Associate Dean for Genome- Based Research, and Ihor Lemischka, PhD, Professor of Gene and Cell Therapy and Director of the Black Family Stem Cell Institute, will serve as Mentor and Co-Mentor, respectively. This applicant will devote 95% of her effort to the career development program which includes: 1) undertaking the proposed laboratory research, 2) training in stem cell biology and iPS techniques, 3) participation in Genetics and Stem Cell Biology Work in Progress sessions, journal clubs and seminars, and attendance at national scientific meetings, and 4) bi-weekly meetings with Mentors. The specific aims of the proposed research are: 1) to investigate the pathogenesis of the life-threatening acute neurological attacks in Acute Intermittent Porphyria (AIP), the most common hepatic porphyria [due to deficient activity of hydroxymethylbilane synthase (HMB-synthase)], and 2) to evaluate the effectiveness of hepatocyte and bone marrow transplantation for AIP as proof-of-concept for future induced pluripotent stem (iPS) cell-based therapies for patients with AIP and the other acute hepatic porphyrias who have recurrent attacks. Towards this goal, Aim 1 will investigate disease pathogenesis in the previously generated T1/T2 AIP knock-down mice that have an inducible biochemical phenotype and in the newly generated AIP knock-in mice (R167Q+/+) that have a severe biochemical and clinical phenotype. Aim 2 will evaluate the effectiveness of primary hepatocyte transplantation and bone marrow transplantation in clearing the accumulated plasma and urinary porphyrin precursors, 4-aminolevulenic acid (ALA) and porphobilinogen (PBG) in the severely affected R167Q+/+ mice. These studies will determine the number of HMB-synthase competent cells necessary to clear the circulating porphyrin precursors and whether the clearance also down-regulates hepatic 5'- aminolevulinic acid synthase 1 (ALAS1) activity. Aim 3 will assess whether transplanting HMB-synthase overexpressing hepatocytes and bone marrow (transduced ex vivo with lentiviral vectors prior to transplantation) can effectively decrease the number of engrafted cells required to clear ALA and PBG accumulation in the R167Q+/+ mice. This is of particular importance, as it is a major challenge to achieve high levels of donor cell engraftment and proliferation for diseases such as AIP that lack hepatocellular damage and thus do not provide the donor cells a proliferative advantage. Based on the results of Aims 2 and 3, Aim 4 will apply the latest iPS technology to develop treatment for the AIP mice as a model for future applications in patients. The rationale for cell transplantation to prevent the acute attacks in AIP is supported by recent studies in our laboratory demonstrating that intraperitoneal injection of an AAV2/8 vector overexpressing HMB-synthase effectively and continuously prevented the biochemical induction of an acute attack in the T1/T2 mouse model of AIP (see Preliminary Results, Section C.3.). This integrated research and educational program, together with the outstanding research environment at Mount Sinai, should facilitate the applicant's transition to an academic career as an independent translational researcher.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research investigates whether transplantation of hepatocytes and bone marrow cells can treat Acute Intermittent Porphyria (AIP), a hepatic disorder resulting from the deficiency of an enzyme that synthesizes heme. Development of a safe and effective treatment should protect patients from the life-threatening acute neurological attacks of AIP and improve their quality of life. Narrative The proposed research investigates whether transplantation of hepatocytes and bone marrow cells can treat Acute Intermittent Porphyria (AIP), a hepatic disorder resulting from the deficiency of an enzyme that synthesizes heme. Development of a safe and effective treatment should protect patients from the life-threatening acute neurological attacks of AIP and improve their quality of life. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The overall goal of this Mentored Research Scientist Development Award is to provide an integrated mentored and educational research program for the applicant that will lead to an independent career in translational research. An organized research project will be carried out in the Mentor's laboratory and the applicant will be trained in stem cell biology and induced pluripotent stem (iPS) cell technology for application to the proposed research protocol. Dr. Robert Desnick, Professor and Chair of the Department of Genetics and Genomic Sciences, and Dr. Ihor Lemischka, Director of Black Family Stem Cell Institute, will serve as Co-mentors. The objectives of the proposed research are: 1) to investigate the pathogenesis of the life-threatening acute neurological attacks in Acute Intermittent Porphyria (AIP), the most common hepatic porphyria due to deficient activity of hydroxymethylbilane synthase (HMB-synthase), and 2) to evaluate the effectiveness of hepatocyte and bone marrow transplantation for AIP as proof-of-concept for future iPS cell-based therapies for patients with AIP and the other acute hepatic porphyrias who have recurrent attacks. Towards this goal, Aim 1 will investigate disease pathogenesis in both the previously generated T1/T2 AIP knock-down mice that have an "inducible" biochemical phenotype and in the newly generated AIP knock-in mice (R167Q+/+) that have a severe biochemical and clinical phenotype. Aim 2 will evaluate the effectiveness of primary hepatocyte transplantation and bone marrow transplantation in clearing the accumulated plasma and urinary porphyrin precursors, δ- aminolevulenic acid (ALA) and porphobilinogen (PBG) in the severely affected R167Q+/+ mice. These studies will determine the number of HMB-synthase competent cells necessary to clear the circulating porphyrin precursors and whether the clearance also down regulates hepatic 5'-aminolevulinic acid synthase 1 (ALAS1) activity. Aim 3 will assess whether transplanting HMB-synthase over-expressing hepatocytes and bone marrow (transduced ex vivo with lentiviral vectors prior to transplantation) can effectively decrease the number of engrafted cells required to clear ALA and PBG accumulation in the R167Q+/+ mice. This is of particular importance, as it is a major challenge to achieve high levels of donor cell engraftment and proliferation for diseases such as AIP that lack hepatocellular damage and thus do not provide the donor cells a proliferative advantage. Based on the results of Aims 2 and 3, Aim 4 will apply the latest iPS technology to develop treatment for the AIP mice using corrected autologous cells as a model for future applications in patients. The PI will be trained in stem cell biology and iPS cell techniques by her Co-Mentor, Dr. Ihor Lemischka, Director of the Mount Sinai Black Family Stem Cell Insitute. The rationale for cell transplantation to prevent the acute attacks in AIP is supported by recent studies in our laboratory demonstrating that intraperitoneal injection of an AAV2/8 vector overexpressing HMB-synthase effectively and continuously prevented the biochemical induction of an acute attack in the T1/T2 mouse model of AIP (see Preliminary Results, Section C.3.) Aim 1. Characterization of a Severely Affected AIP Mouse Model for Studies of Disease Pathogenesis and Therapy Recently, we generated HMB-synthase knock-in mice with the R167Q mutation, which causes severe homozygous dominant AIP (HD-AIP) in humans. Similar to HD-AIP patients, homozygous R167Q mice (designated R167Q+/+) have ~5% residual HMB-synthase activity and constitutively elevated levels of plasma and urinary ALA and PBG, the biochemical hallmarks of an acute attack. Clinically, the R167Q+/+ mice are runted, ataxic, and have impaired performance on rotarod and footprint analyses. These mice, and previously generated T1/T2 HMB-synthase mice that have ~30% residual activity and accumulate ALA and PBG only when heme biosynthesis is induced by administration of porphyrinogenic agents such as phenobarbital, will be characterized using biochemical, histological, and molecular analyses. In particular, gene expression levels of heme biosynthetic and related/interacting genes (e.g., ALAS1, Heme Oxygenase1) will be assessed by RNA-Seq, and the pathways and processes in the liver and brain that are perturbed in these severely affected mice will be globally analyzed in order to investigate the molecular and biochemical pathogenesis of the acute neurological attacks in these murine AIP models. Aim 2. Effect of Primary Hepatocyte and Bone Marrow Transplantation on the Biochemical and Neurologic Abnormalities in the R167Q+/+ Mice The effectiveness of hepatocyte and bone marrow transplantation and the degree of normal cell replacement necessary to correct the pathological accumulation of porphyrin precursors in the R167Q+/+ mice will be evaluated using luciferase-tagged cells. Primary hepatocytes and bone marrow cells will be isolated from transgenic mice ubiquitously expressing luciferase and transplanted into immunocompromised adult R167Q+/+ mice by intrasplenic and tail vein injections, respectively. Serial injections of carbon tetrachloride (CCl4) will be given before and after transplantation, to induce hepatocellular injury in the host liver to provide the transplanted cells a proliferative advantage. To determine the minimal number of HMB-synthase competent cells necessary to clear plasma and urinary ALA and PBG, R167Q+/+ mice will be administered decreasing doses of hepatotoxic CCl4 to stimulate donor cell proliferation at reduced rates. Plasma and urinary ALA and PBG levels will be quantitated by LC/MS-MS mass spectrometry to assess the effectiveness of these therapies, while rotarod and foot-print analyses will evaluate their impact on neuromotor function. The efficiency and persistence of hepatocyte engraftment will be assessed by in vivo bioluminescence imaging and immunohistochemistry, and the corresponding hepatic HMB-synthase activities will be determined. Studies will evaluate whether ALAS1 is down-regulated or if the enzyme-competent transplanted cells simply clear the soluble circulating porphyrin precursors synthesized in the liver. Aim 3. Evaluation of Ex-Vivo Lentiviral Transduced Hepatocyte and Bone Marrow Transplantation to Correct Porphyrin Precursor Accumulation in R167Q+/+ Mice Efforts will determine whether transplantation of HMB-synthase-overexpressing hepatocytes and bone marrow cells can minimize the number of engrafted cells necessary to correct the porphyrin precursor accumulation in the R167Q+/+ mice. Luciferase-tagged primary hepatocytes and bone marrow cells will be isolated from transgenice mice and transduced ex vivo with lentiviral vectors expressing FLAG-fused murine HMB-synthase. Immunosuppressed R167Q+/+ mice will be grouped and pretreated with different doses of CCl4, to facilitate donor hepatocyte engraftment and proliferation. Virally transduced hepatocytes and bone marrow cells will be transplanted into immunosuppressed R167Q+/+ mice by intrahepatic and tail vein injections, and the number of transplanted cells necessary to clear the ALA and PBG accumulation will be determined. As in Aim 2, the effectiveness of these therapies to correct the neuromotor abnormalities of AIP will be assessed, and persistence of hepatocyte engraftment will be determined. The virally-transduced hepatocytes will be quantitated by immunostaining for the FLAG octapeptide. Aim 4. Application of iPS Technologies for the Treatment of the Acute Hepatic Porphyrias Murine iPS cells will be derived from appropriate adult R167Q+/+ cells using transient expression of reprogramming genes, transduced with the wild-type murine HMBS gene using a lentiviral vector, and selected for non-oncogenic properties. This corrected iPS line will be induced towards erythroid differentiation using techniques routine in the Lemischka laboratory and evaluated in the treatment of the severely affected R167Q+/+ mice by bone marrow transplantation. Similarly, if murine hepatocytes can be derived from iPS reprogrammed cells, they will be transduced with lentiviral-vectors overexpressing HMB-synthase, transplanted into the AIP mice, and their effectiveness in treating the acute porphyria will be evaluated. The proposed studies represent a logical extension of the Mentor's NIH-funded efforts to investigate the pathophysiologic mechanisms underlying the hepatic and erythropoietic porphyrias and to develop and evaluate novel therapies for these diseases. Previously, Dr. Desnick's laboratory cloned several of the murine and human heme biosynthetic genes, characterized the biochemical defects in the human porphyrias, and generated mouse models for studies of disease pathogenesis and treatment. This proposal is designed to provide mentored career development for Dr. Yasuda, a talented physician-scientist devoted to a research career to translate basic understanding of disease pathogenesis into new and effective therapies for AIP by implementing the latest developments in cell and gene therapy. It should be emphasized that Dr. Yasuda generated the severely affected R167Q+/+ mice that are critical to the proposed studies and performed the AAV2/8 gene therapy experiments in the T1/T2 HMB-synthase mice that provided the rationale for the proposed cell therapy research. This research proposal was entirely developed and written by Dr. Yasuda.